Diversity Supplement: Natural Product-Inspired Approaches Toward The Development Of Antivirulence And Species-Specific Inhibitors

This document is not a requirement for this submission.

Public health relevance
This document is not a requirement for this submission.